Daily Ovarian Hormone Exposure and Loss of Control Eating in Adolescent Girls: A Within-Day RDoC Study

PROJECT SUMMARY/ABSTRACT
In adolescent girls, loss of control (LOC) eating is a maladaptive eating behavior associated with psychiatric
morbidity, including the development of full syndrome eating disorders. However, the daily biobehavioral
factors that precipitate LOC eating are not well known. Ovarian hormone levels are key biological factors
associated with the etiology of eating disorders in adolescent girls. Yet, models on how daily ovarian hormone
exposure predicts LOC eating in adolescent girls are underdeveloped. Two relevant research domain criteria
(RDoC) implicated in eating disorders include reward anticipation and response inhibition. These processes
associate with variations in ovarian hormone levels, and thus, daily hormone exposure may cause
dysregulation in reward anticipation and response inhibition, which may in turn precipitate LOC eating. Given
the substantial gap in research on daily hormone exposure and LOC eating in adolescent girls including
momentary mediating mechanisms, the goal of this study is to examine the patterns and mechanisms of
ovarian hormone exposure on LOC eating across the menstrual cycle in adolescent girls. Ecological
momentary assessment (EMA) paired with daily hormonal sampling will be used to examine daily and
momentary associations between daily hormone exposure and LOC eating and the mediating role of
momentary fluctuations in reward anticipation and response inhibition. Normally cycling adolescent girls who
have reached menarche will provide daily saliva samples for hormone analysis and be administered EMA for
35 days on mobile phones. During EMA, girls will report LOC eating and will complete measures of response
inhibition and reward anticipation. This study has two specific aims. Specific Aim 1 is to characterize the
association between daily hormone exposure and LOC eating in adolescent girls, and Specific Aim 2 is to
examine a mediation model of daily hormone exposure and momentary RDoC constructs (i.e., response
inhibition and reward anticipation) in predicting LOC eating. This work has implications for the development of
new real-world biobehavioral models of LOC eating in adolescent girls within the RDoC framework, which will
guide future theoretical developments and treatment for LOC eating. For example, results will provide
preliminary evidence for treatment targets for novel interventions for adolescent girls—e.g., a response
inhibition intervention may be needed during phases of the menstrual cycle characterized by specific hormonal
profiles.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Adolescent eating disorders are severe mental health conditions, often marked by loss of control eating. Ovarian hormones play a role in the development and persistence of loss of control eating. The current application will examine how daily exposure to ovarian hormones predict loss of control eating in adolescent girls and identify possible momentary mechanisms linking ovarian hormone exposure and loss of control eating.